Structural and Biochemical Mechanisms of Microtubule Dynamics and Regulation

Microtubules (MTs) are essential dynamic polymers required for chromosome segregation and intracellular
organization, and are the direct targets of anti-cancer chemotherapeutics like taxol and the Vinca alkaloids. The
dynamic properties of MTs are central to their function, and they derive from the structural and biochemical
properties of individual tubulin subunits and how they interact within the MT lattice. It is increasingly
appreciated that tubulin subunits adopt distinct conformations as part of the GTPase-dependent polymerization
dynamics, and that regulatory proteins selectively recognize subsets of these conformations to control MT
elongation, stability, and switching. Research in the laboratory uses a combination of structure (X-ray
crystallography and cryo-EM), quantitative biochemistry, time-lapse observation of microtubule dynamics, and
computational simulations. Mechanism-specific, site-directed tubulin mutants are used to integrate the different
sources of information and also to test hypotheses and create new tools. In the present proposal, we will focus
on complementary lines of investigation to provide new insights into the physical origins and regulatory
mechanism of MT dynamics. We will reveal the allosteric logic of the tubulin conformation cycle and provide
fresh biochemical insight by studying newly identified mutations linked to microtubule stability. We will use
single-molecule observations of tubulins interacting with microtubule ends to define and quantify biochemical
mechanisms and generate new hypotheses. We will reveal how relatively divergent α-tubulin isotypes and/or
primitive tubulins alter MT dynamics and structure. Finally, we will define how specialized TOG domains
recognize tubulin and/or MTs to regulate MT dynamics. This work will advance understanding of fundamental
mechanisms of MT dynamics, recognition, and regulation, and it will begin to reveal critical points of allosteric
connection within αβ-tubulin. Longer-term goal of this research are: to build a quantitative molecular
understanding of how allostery and the tubulin conformation cycle dictate MT stability, dynamics, and
mechanochemistry, to define mechanisms by which regulatory factors recognize tubulin and control MT
dynamics, and to place this knowledge more firmly into a functional context.

Public health relevance
Microtubules are dynamic polymers of ab-tubulin that mediate the internal organization of cells and the faithful segregation of genetic material, and that are the direct targets of some chemotherapeutic drugs. Dynamic microtubule behavior and how it is regulated remain poorly understood, in part because it is challenging to connect static measurements of structure and biochemistry to the polymerization dynamics. This work will advance mechanistic understanding using new reagents combined with approaches including structure, biochemistry, single-molecule measurements, and modeling to provide molecular insight into the basic workings of microtubule dynamics and how regulatory factors control them.